Neural mechanisms underlying the prioritization of protein-rich foods during protein need states.

PROJECT SUMMARY/ABSTRACT
Dietary protein or essential amino acid intake is crucial for survival, and evidence indicates that
the body adaptively responds to reductions in protein intake by altering its feeding behavior. The
Morrison Lab has previously shown that these adaptive changes in feeding behavior under
protein restriction are driven by FGF21 signaling in the brain through its interaction with the co-
receptor beta-klotho (Klb). Specifically, protein restriction leads to an increase in food intake, a
shift in macronutrient preference from carbohydrates to protein, and heightened motivation
toward protein, all of which are reliant on FGF21 signaling in the brain. However, the
mechanism by which protein-restricted animals distinguish and prioritize foods based on their
protein content remains unclear. Therefore, the goal of this F32 project is to understand how the
brain discerns and values dietary protein by: 1) assessing animals' ability to learn and associate
intestinal protein cues with novel flavors, evaluating the roles of vagal transmission and FGF21
signaling, and 2) determining whether intestinal protein cues activate dopamine neurons in the
brain and if Klb neurons project to these dopamine neurons, thereby influencing the reward
value of intestinal protein. This research will shed light on the interaction between short-term
meal-related protein signals and the long-term protein restriction signal, FGF21. Ultimately, it
seeks to bridge the gap in our understanding of macronutrient preferences, which has
predominantly focused on fats and carbohydrates, thereby deepening our insight into the
complex decision-making processes behind food choices. This could lead to the development of
tailored nutritional interventions aimed at promoting healthy eating habits in individuals
struggling to maintain a healthy diet.

Public health relevance
PROJECT NARRATIVE Our project aims to elucidate the neural mechanisms that drive the prioritization of protein-rich foods under protein restriction, a critical adaptive response that directly influences metabolic health. We will investigate how the brain distinguishes and values protein foods by evaluating the importance of vagal transmission and FGF21 signaling in protein preference learning and by mapping neural circuits in the brain that connects dopamine neurons and beta-klotho, FGF21 co-receptor, expressing neurons. This research will close the gap in our understanding of macronutrient preferences, which has predominantly focused on fats and carbohydrates, thereby enhancing our insight into the complex decision-making process behind food choices.